A stalled chromatin regulatory network that mediates the oncogenic activity of Meningioma-1

PROJECT SUMMARY
High expression of the transcriptional co-activator Meningioma-1 (MN1) is common in AML, and associated
with a poor prognosis. Forced expression of MN1 in murine hematopoietic progenitors induces an aggressive
leukemia. We recently discovered that the primary interaction partner of MN1 is the BAF nucleosome-
positioning complex. MN1 stabilizes BAF on chromatin. MN1 binding is associated with sustained active
enhancer chromatin at enhancers regulating a hematopoietic stem/progenitor program. We hypothesize that
MN1 stabilizes promoter-enhancer contacts at these sites through a BAF dependent mechanism. The goal
of this project is to uncover the molecular mechanism of MN1-mediated leukemic transformation. A better
understanding of how MN1 causes leukemia may identify opportunities for targeted therapies in a patient
population who is failing conventional AML therapy.

Public health relevance
PROJECT NARRATIVE In 2014 there were an estimated 20,000 new cases of acute myeloid leukemia (AML) resulting in over 10,000 deaths. 20-25% of AML have very high expression of a gene called Meningioma-1 (MN1), and most of these patients have a very poor prognosis. We propose that MN1 causes leukemia by interfering with appropriate gene regulation, and that identifying critical mechanisms involved in this process may generate a path towards developing specific inhibitors that could help treat AML.